Antibodies as Drugs

ABSTRACT Support is requested for a Keystone Symposia conference entitled Antibodies as Drugs organized by Drs. Pierre Bruhns, Patrick C. Wilson, Esther Breij and David P. Humphreys. The conference will be held in Whistler, British Columbia from January 27-30, 2021. Therapeutic antibodies continue to largely populate the list of top biologic drugs. They revolutionize the treatment of pathologies falling into major disease areas, which include cancer, chronic inflammatory diseases, allergy and infectious diseases. As more antibodies are being tested to treat an expanding number of pathologies, there has also been a concomitant increase in the frequency of resistance and escape mechanisms. Thus, researchers are exploring alternative concepts to prevent unresponsiveness or treat resistant patients. Therefore, not only are new methodological and technological advances being developed, paradigm-shifting concepts are being developed in order to face these challenges. This conference in the Keystone Symposia series on Antibodies as Drugs aims to present the state-of-the-art in antibody therapeutics, repertoires and deep learning, bispecific antibodies and engineering. This conference will provide a forum for extensive interactions between investigators from both industry and academia. Goals of this conference include discussion of recent breakthroughs in identifying therapeutics from patients, understanding vaccination and mode of delivery, modalities for half-life extensions and involvement of complement in antibody mode of action. It is anticipated that research in the field will showcase the rise of bispecific antibodies and highlight the technologies to develop them, improve their functionalities, and boost clinical efficacies, particularly in immune-oncology.

Public health relevance
PROJECT NARRATIVE The success of early antibody approaches has been tremendous and now they have revolutionized treatment for many major disease areas, such as cancer, chronic inflammatory diseases, allergy and infectious diseases. However, as more antibodies are being tested to treat an expanding number of pathologies, then more resistance and escape mechanisms are being found, forcing scientists to search for alternative concepts to prevent unresponsiveness or treat resistant patients. Therefore, this conference will gather scientists from many different disciplines, including structural and cellular immunology, biology, engineering, chemistry and medicine, to share ideas and help develop novel antibody therapeutics.